Identifying the role of interferon and interferon-regulated chemokines in stress-induced immunosuppression in triple negative breast cancer

ABSTRACT
In the United States, breast cancer is the most commonly diagnosed cancer and second leading cause of cancer-
related deaths among women of all ages and racial/ethnic groups. Immune checkpoint inhibitors (ICIs) are
currently being used for the treatment of triple negative breast cancer (TNBC), which comprises 15% of all breast
cancer diagnoses, especially in younger women, and is the most aggressive and lethal subtype; however, only
5-20% of TNBC patients are responsive to current ICI monotherapy and new strategies are urgently needed to
help others overcome treatment resistance. One mechanism of resistance to ICIs is lower expression levels of
intratumoral chemokines CXCL9 and CXCL10 that are essential for attracting anti-tumor CD8+ T cells to the
tumor microenvironment (TME). The proposed research will evaluate whether stress-induced molecular
pathways are linked to the expression of these chemokines. Psychosocial stress is associated with both
increased incidence and mortality of breast cancer according to epidemiological studies, and between 30-75%
of breast cancer patients experience psychological stress, which can enhance β-adrenergic signaling,
potentially reducing the efficacy of ICIs. However, the specific role of psychosocial stress in the development
of treatment resistance to ICIs among TNBC patients remains unknown. Our team's research in preclinical
mouse models has shown that chronic stress and its mediators, epinephrine (EPI) and norepinephrine (NE),
drive immunosuppression in the TME by decreasing CD8+ T cells and increasing immunosuppressive cells, thus
promoting tumor growth. Our subsequent study provided preliminary evidence that propranolol, a pan-β-blocker,
improves responses to ICIs in patients with metastatic melanoma from 30-40% to 78%. We also found that
chronic stress via EPI increases prostaglandin E2 (PGE2). Further, we and others have shown that PGE2 inhibits
interferon (IFN)-induced CXCL9 and CXCL10 secretion. Thus, we hypothesize that chronic stress promotes
immunosuppression in TNBC by increasing PGE2 and inhibiting IFN pathways, which ultimately leads
to decreases in CXCL9 and CXCL10. We will test our hypothesis by correlating validated measures of
psychosocial stress with levels of IFN, PGE2, CXCL9 and CXCL10, and immune cells in prospectively collected
tumor tissues from breast cancer patients. The proposed study will (i) investigate a novel mechanistic pathway
of stress-induced tumor progression and (ii) be the first to test if high levels of perceived stress are associated
with immunosuppression in a study using human breast cancer samples. Completion of the proposed work is
expected to provide crucial insights into the role of the PGE2-IFN-chemokine pathway in stress-induced
immunosuppression in the TME, which will allow us to develop future competitive NIH grant proposals (e.g.,
R01) to obtain a comprehensive understanding of this pathway and its potential to be therapeutically targeted.
This could eventually lead to improved clinical outcomes for not only patients with immunotherapy-
resistant TNBC, but also other cancer patients affected by tumor immunosuppression.

Public health relevance
PROJECT NARRATIVE A substantial proportion (>75%) of patients with triple negative breast cancer, a particularly aggressive and lethal type of breast cancer, exhibit resistance to single-agent frontline immunotherapies called immune checkpoint inhibitors. Presently, psychosocial stress, which is experienced by many breast cancer patients, remains an understudied and underappreciated contributor to treatment resistance to immune checkpoint inhibitors. In the proposed work, we will determine if there are correlations between self-reported stress scores and molecular markers reflective of stress-induced immunosuppression in tumor tissues collected from women with breast cancer, and we hope to eventually use the insights gained to develop new therapies that can reverse this form of immunosuppression and improve survival rates in patients with immune checkpoint inhibitor-resistant triple negative breast cancer and beyond.